Molecular Mechanisms of Oligodendrocyte Myelination and remyelination

Summary of Proposed Research
Demyelinating diseases of the central nervous system, such as multiple sclerosis (MS), are among the
most devastating and disabling neurological disorders that lead to severe handicaps and even death.
Although substantial efforts have been made centered on the suppression of the immune response that
attacks myelin, it is becoming clear that this approach does not address the major problem of the disease:
the loss of myelin. A common feature in the demyelinated lesions is the blockage of myelin production by
oligodendrocytes. Thus, the identification of critical factors that promote myelin production from
oligodendrocytes and block inhibitory signals impeding myelination will help devise effective strategies for
improving myelin repair in demyelinating diseases.
Epigenetic reprogramming has been shown to rejuvenate cellular activity and thus is a promising
approach to enhance repair capacity after injury. Our unprecedented screen using CNP+ oligodendrocytes
identified epigenetic compounds that potently stimulate for myelin production and myelinogenesis. The top
hit compound promotes remyelination in animal models of MS and initiates de novo myelination of
regenerated axons after optic nerve crush. Our preliminary data suggest that the histone deacetylase
HDAC3 is a target of the hit compound. Expression of HDAC3 is detected in oligodendrocytes that fail to
produce myelin in human demyelinated MS lesions. Moreover, silencing of HDAC3 led to ectopic
myelinogenesis in the developing brain and promoted robust remyelination after injury. Since the cellular
specificity and function of HDACs are dependent on subunit compositions and interacting factors in multi-
protein complexes, we further identified an HDAC3-interacting protein, the zinc-finger protein Znhit1, which
is a key subunit of SNF2-related SRCAP chromatin-remodeling enzyme. Our preliminary data show that
Znhit1 is enriched in oligodendrocytes and critical for oligodendrocyte myelination, while overexpression of
Znhit1 promotes myelin gene expression. Based on these observations, we will utilize spatio-temporally
specific mutagenesis approaches to identify the critical time window for the function of class I histone
deacetylase isoforms in remyelination in animal models of MS and identify the HDAC3-Znhit1 regulatory
network in myelination and remyelination. Furthermore, we will determine the therapeutic benefits of
HDAC3 inhibitors for myelin repair. The proposed studies will advance our understanding of the
mechanisms of central nervous system myelination and will also identify factors that could be targeted to
promote oligodendrocyte regeneration and myelin repair in patients with demyelinating diseases such as
MS, aging, leukodystrophies, stroke, autism, and injury to the brain or spinal cord.

Public health relevance
Project Narrative Demyelination in the central nervous system can cause a variety of neurological disorders by disrupting nerve conduction, as well as cognitive and motor functions. The proposed research will provide a better understanding of the molecular mechanisms controlling myelin production and regeneration. This aligns with the NIH’s mission as the studies will not only have scientific merits but also could offer new treatment strategies for neurodegenerative diseases, including multiple sclerosis, Alzheimer's disease, autism, cerebral palsy, spinal cord injuries, and age-related neurological decline.